Mucin Glycans in the Regulation of Microbial Virulence

PROJECT SUMMARY/ABSTRACT
The goal of this project is to decipher the mucin glycan code that regulates microbial virulence. A layer of thick,
well-hydrated mucus is a key defense mechanism on epithelial linings such as on the mouth, gastrointestinal
tract, and lungs. The exceptional molecular diversity and complexity of glycans associated with mucin
polymers, the gel-forming building blocks of mucus, has been recognized for decades. However, their potential
for regulating interactions between a host and its associated microbes has barely been tapped because the
individual bioactivities of glycans have been intractable to analysis. Our results from the past funding period
support a central role for mucin glycans in host protection by regulating cross-kingdom virulence; our results
also strongly support the relevance and feasibility of the proposed efforts to identify the glycan structures and
mechanisms responsible for antivirulence effects. We propose to combine functional analysis with bottom-up
engineering of mucin-like glycans and polymers to unravel the design principles of glycan signals and the
mucin regulatory code. This knowledge will empower us to begin to elucidate, and ultimately harness, the
myriad biological consequences of glycans and mucins on microbes and their hosts. In Aim 1, we will harvest
bioactive glycans from mucins to generate annotated libraries from isolated mucin O-glycans for functional
analysis from the major mucosal surfaces in the body, including the mouth, lungs, and digestive tract. These
libraries will allow, for the first time, functional studies to obtain insight into mechanisms and chemistries of O-
glycans that affect host-microbe interactions, such as glycan size, specific residue sequence, glycan linkages,
and geometry. In Aim 2, we will identify the mechanisms by which mucin O-glycans attenuate virulence in two
important human mucosal pathogens, Pseudomonas aeruginosa and Candida albicans, which are becoming
increasingly resistant to treatment. In Aim 3, we will characterize the anti-virulence effects of mucin O-glycans
in a well-established pre-clinical in vivo infection model. In Aim 4, we will integrate the knowledge from Aims 1-
3 to engineer prioritized O-linked glycosylated mucin-like polymers with previously unattainable precision. This
project directly addresses an urgent health care problem: antimicrobial resistance is spreading rapidly and
demands new approaches to combat problematic pathogens. We expect to deliver new concrete chemical
design parameters and molecules to manage two problematic pathogens that are becoming increasingly
resistant to treatments. The multidisciplinary team has the expertise necessary for combining fundamental
science questions with pre-clinical validation and cutting-edge engineering applications: a biologist with
experimental and theoretical expertise in mucus hydrogel systems, a microbiologist with expertise in in vivo
infection models, and a chemist with expertise in controlled glycan and polymer synthesis and characterization.

Public health relevance
PROJECT NARRATIVE A layer of thick, well-hydrated mucus is a key defense mechanism on epithelial linings such as on the mouth, gastrointestinal tract, and lungs. The exceptional molecular diversity and complexity of mucin-associated glycans has been recognized for decades, but their potential for regulating interactions between a host and its associated microbes has barely been tapped because the individual bioactivities of glycans have been intractable to analysis. This proposal will combine functional analysis with bottom-up engineering of mucin-like glycans and polymers to unravel the design principles of glycan signals and the mucin regulatory code, empowering us to begin to elucidate, and ultimately harness, the myriad biological consequences of glycans and mucins on microbes and their hosts.